Advancing Precision Medicine for ARDS and Sepsis

Abstract:
The acute respiratory distress syndrome (ARDS) and sepsis are common causes of death in critically ill
patients, yet both are clinical syndromes defined by non-specific signs and symptoms which encompass major
clinical and biological heterogeneity. Pre-clinical studies have identified numerous promising therapeutic agents
for both ARDS and sepsis, but clinical trials of novel pharmacotherapies in these syndromes have been
persistently negative, in large part due to this aforementioned heterogeneity. Thus, new approaches are needed
to improve patient outcomes.
We and others have identified two molecular phenotypes of ARDS and sepsis, termed “hyperinflammatory”
and “hypoinflammatory,” in numerous cohorts. These phenotypes are defined by a combination of readily
available clinical data and plasma protein biomarkers and have widely divergent clinical outcomes, with the
hyper-inflammatory phenotype having, on average, double the in-hospital mortality of the hypoinflammatory
phenotype. The hyperinflammatory phenotype appears to be a treatable trait which is present across syndromic
diagnoses (i.e. in both ARDS and sepsis) and which responds preferentially to numerous therapies, including
mechanical ventilation, fluid therapy, simvastatin, activated Protein C, and corticosteroids. This research has
laid the foundation for a new paradigm for clinical research and treatment in critical care medicine and has
already had a major impact on the field. However, several critical unanswered questions remain about the key
differences in the functional immune response and/or pathogens driving these phenotypes, the biological
pathways that represent key mechanistic nodes and potential druggable targets in each phenotype, and how to
optimize real-time phenotyping and integrate analyses of phenotype-specific treatment responses into
contemporary clinical studies. This proposal aims to address those key unanswered questions using 3
innovative and complementary strategies: (1) deep phenotyping of human samples using immunoprofiling and
metagenomics, including analyses of trajectories of recovery; (2) in vivo and in silico modeling of inflammatory
phenotypes to identify potentially effective targeted therapies; and (3) collaboration with clinical networks around
the world to embed phenotyping into ongoing prospective studies and seek evidence for phenotype-specific
treatment effect in contemporary trials. Our group is ideally positioned to address these key questions by virtue
of our expertise in translational science and molecular phenotyping, including sophisticated analyses of high-
dimensional data and experimental models of ARDS and sepsis, and our extensive experience studying both
large RCT databases and our own hand-curated observational cohorts representing real-world patients. With
the support of this new NHLBI R35 Outstanding Investigator Award, we aim to take the new paradigm developed
by our current R35 from proof-of-concept to implementation in clinical research, and ultimately to impacting
clinical care for our patients.

Public health relevance
Narrative: The acute respiratory distress syndrome (ARDS) and sepsis (a life-threatening response to severe infection) are common causes of death in critically ill patients, with no specific treatments available other than supportive care. We and others have identified two distinct subtypes of ARDS and sepsis, which may point the way to more effective treatments. The goals of this project are to improve our understanding of the biological differences between these two subtypes, to identify potential new treatments for each subtype, and to overcome practical barriers to implementing new treatments for these subtypes, in order to improve outcomes for critically ill patients.